A Puff Topography Biofeedback Paradigm to Reduce Stress-Precipitated Smoking Reinforcement

PROJECT SUMMARY/ABSTRACT
Smokers with emotional distress are particularly vulnerable to smoking reinforcement due to various
biopsychological factors that contribute to deficits in emotion regulation and heightened reward processing,
which undermine cessation efforts. The timing and intensity of one's puffing (i.e., puff topography) can titrate or
maximize the cigarette's rewarding effect. Our group has identified puff topography as a core driver of smoking
reinforcement, especially in emotionally distressed smokers. Although largely considered a behavioral
phenotype of smoking reinforcement, inherent in puffing behavior are corresponding changes in
cardiorespiratory parameters (e.g., cardiac vagal control, CVC) that may promote self-regulation and reduce
craving. In our integrated psychophysiological model of emotional distress and smoking, we proposed that in
smokers, impaired CVC not only implicates physiological homeostasis, but also influences addiction-relevant
processes, including impaired higher-order cognitive processes needed for self-regulation and psychological
functioning (e.g., reduced anxiety and stress).Yet, under certain time-sensitive contexts (e.g., stress),
emotionally distressed smokers may puff in a way that enhances CVC, resulting in acute self-regulatory
benefits, and in turn paradoxically amplifies the reinforcing value of each puff. Thus, a bio-behavioral
intervention that could modify puff topography and CVC has the strong potential to reduce the reinforcing value
of cigarettes in high-risk emotionally distressed smokers. Grounded in our biobehavioral framework, we
designed a highly innovative bio-behavioral paradigm, called Puff Topography Biofeedback Training (PTBT) to
directly target putative bio-behavioral underpinnings of smoking reinforcement (i.e., puffing topography and
CVC). PTBT leverages in vivo monitoring of respiratory parameters (i.e., biofeedback) that occurs during
smoking so that puffing is constrained to a pace that is designed to minimize CVC in order to attenuate acute
self-regulatory, emotional, and craving reduction associated with smoking reinforcement. In this R1, we
propose a between-subjects experimental test of PTBT and its ability to modify puff topography and CVC
during stress-precipitated smoking, and in turn, reduce acute smoking reinforcement. Emotionally distressed
daily smokers (N=88, 50% female) will be randomized to PTBT or Control; which are matched for time and
attentional demand. Participants will complete two smoking trials on two successive days using either
PTBT/Control. The first smoking trial (Visit 1) will allow participants to gain familiarity with the task. The second
smoking trial (Visit 2) will be completed following acute laboratory stress induction (stress-precipitated smoking
trial). The primary study aims are to test the effect of PTBT vs. Control, in terms of: acute changes in stress-
precipitated smoking reinforcement (tobacco demand; cigarette reward; satisfaction) and changes in
mechanisms (puff duration, CVC). The results of this high pre-intervention study could inform the subsequent
development of a novel intervention strategy for improving quit outcomes in a treatment-resistant population.

Public health relevance
PROJECT NARRATIVE Smokers with emotional distress are particularly vulnerable to the reinforcing effects of cigarettes. We propose an integrated biopsychological framework that implicates puffing style (i.e., topography) and cardiorespiratory underpinnings of self-regulation and smoking reward. We will test whether a novel puff topography biofeedback paradigm (vs attention-matched control paradigm) modifies these bio-behavioral targets (i.e., puff duration; cardiac vagal control), and in turn, produces acute reductions in stress-precipitated smoking reinforcement.